Evaluating Maintenance In Light chain Amyloidosis (EMILIA)

PROJECT SUMMARY/ABSTRACT
Light chain (AL) amyloidosis is a rare plasma cell disorder. It is caused by abnormal misfolding of monoclonal
immunoglobulin light chains causing extracellular deposition of amyloid, which ultimately results in organ
dysfunction and death. The treatment goal in AL amyloidosis is elimination of the production of the
amyloidogenic light chains by means of anti-plasma cell therapies, which can allow for organ recovery and
extended survival. The phase III randomized ANDROMEDA study, which showed superiority of daratumumab-
CyBorD over CyBorD induction in the rate of complete hematological response and overall hematological
response rate, established the standard of care for newly diagnosed AL amyloidosis as daratumumab-CyBorD.
However, the study continued with daratumumab maintenance for up to 18 cycles in those receiving
daratumumab-CyBorD induction, in a non-randomized manner, thus providing no proof of the need for
maintenance therapy in this disease or for its optimal duration. Our main objective in this study is to assess the
optimal duration of maintenance in the post-Andromeda era. The proposed study is a phase II randomized
study where patients achieving adequate hematological response to daratumumab-CyBorD induction will be
randomized in a 1:1 ratio to single agent daratumumab maintenance of 6 months (experimental arm), versus
18 months of daratumumab maintenance (control arm). The study will have a pragmatic trail design with the
use of broadened eligibility criteria to allow participants at different stages of the disease to take part. In Aim 1,
the primary assessment of efficacy will be event-free survival (EFS). In Aim 2, we will assess secondary
efficacy endpoints including hematological response; measurable residual disease (MRD) assessed by next
generation multiparametric flow cytometry; depth of organ response; adverse events (especially infections and
IVIG use); time to next therapy, and overall survival. In Aim 3 we will assess patient-reported quality of life
assessed in a longitudinal manner throughout maintenance and after maintenance completion using the
PROMIS29 questionnaire and selected items from the PRO-CTCAE questionnaire. The study will be
conducted at Mayo Clinic campuses in Arizona, Florida, and Minnesota with 96 patients planned to be accrued
to meet the statistical design for a non-inferiority study. The study’s key strength is its design as a pragmatic
trial, thus reflecting real world practice. As part of that, we will allow treatment by the local medical doctor with
interval visits to the Mayo Clinic campus for efficacy and safety assessments. We bring a research alliance in
plasma cell disorders between the three Mayo Clinic campuses. Lastly, MRD testing and quality of life
assessment are innovative tools in clinical research in AL amyloidosis, and will be assessed longitudinally in
this study.

Public health relevance
PROJECT NARRATIVE Maintenance therapy with daratumumab, an anti-CD38 monoclonal antibody, has become a common practice in AL amyloidosis, yet has no proven efficacy. In this randomized phase II study, we aim to compare an abbreviated schedule of daratumumab maintenance to the currently accepted prolonged schedule of daratumumab maintenance following daratumumab-CyBorD induction among patients with newly diagnosed AL amyloidosis. This work will assess the no-inferiority of abbreviated daratumumab maintenance schedule with the standard duration of daratumumab maintenance therapy from several perspectives, including depth of hematological and organ response, bone marrow measurable residual disease negativity rate, duration of response, quality of life, and survival.